Texas A&M Center for Environmental Health Research (TiCER)

Administrative Core ABSTRACT
The Administrative Core will provide leadership and guidance to the Texas A&M Center for Environmental
Health Research (TiCER) to ensure excellence of research integration, community engagement, research
translation, and career development. The overall theme of the Center is “Innovative solutions for addressing
exposure-stressor interactions with a focus on underserved populations in urban and urbanizing areas” in the
state of Texas. The Administrative Core will serve as the focal point for the Center and provide the support
infrastructure to promote cross-discipline interactions among all members, facility cores, and external
stakeholders. The Administrative Core will be physically located in the Reynolds Medical Building centrally
located on the Texas A&M University campus in College Station. The overall strategy of the Administrative Core
will be to facilitate regular interactions among Center members, track products and outcomes, develop and plan
future activities, and guide and sustain growth of environmental health research at Texas A&M. The Executive
Committee (EC) of the Administrative Core will coordinate tracking Center progress during monthly meetings.
The EC, along with facility core directors and theme leaders, will form a Program Committee that will meet
quarterly and be responsible for: (i) planning Center activities; (ii) evaluating progress and considering solutions
for challenges; (iii) improving Center integration; (iv) advising on personnel matters; (v) assessing quality
management/assurance; (vi) organizing the annual retreat; and (vii) evaluating community engagement, training,
and research translation activities. An Internal Advisory Board (IAB) consisting of senior university leadership
will advise the Center in matters of internal organization. Scientific oversight of the Center will be the
responsibility of an External Advisory Board (EAB), which will meet annually in conjunction with the Center retreat
to perform program evaluation of the Center and determine whether research, outreach, career development,
and translation goals and objectives are being met. The goals of the Administrative Core will be achieved through
four aims: 1) Provide effective center leadership; 2) Maintain an active membership; 3) Enhance coordination,
integration, and translation of research; 4) Promote career development.